Understanding layer-specific contributions to perception and learning in human cortex

Understanding how feedforward information from primary sensory cortices and feedback
information from ‘higher-order’ brain areas are organized across cortical layers in regions that
are involved in complex perceptual and learning processes is fundamental to understanding
sophisticated cognitive functions and treating related mental disorders. Recently, a cutting-edge
functional MRI (fMRI) method called vascular space occupancy (VASO) has made it possible to
use fMRI to probe cortical layers in humans. However, while VASO has made it possible to
study the functional organization of cortical layers in behaving adult humans, most layer-fMRI
studies to date have focused on primary sensory and motor cortices, leaving higher-order
cortex, and thus many sophisticated mental processes, understudied. Furthermore, layer-fMRI
results thus far have not been validated by correlating changes in layer-specific activation with
behavioral and cognitive measures. The main hypotheses being tested in the proposed
research are that feedforward and feedback information can be reliably dissociated across
layers of human cortex both within and beyond primary sensory and motor cortices, and these
layer-specific responses have a meaningful and measurable relationship to cognition and
behavior. The specific aims of this project are: 1) to validate layer-fMRI results by determining
the behavioral relevance of layer-specific cortical changes; 2) to map feedforward and feedback
signals to specific layers of domain-specific regions in ventral occipital temporal cortex (VOTC),
and thus provide evidence for prominent models of laminar circuitry in ‘high-level’ visual regions
outside of primary visual cortex; and 3) to examine how representations of different viewpoints
of faces and their identities change across layers of the fusiform face area. Validating layer-fMRI
methods and mapping the functional organization of layers in human cortex will push the field of
neuroimaging into a new era of in-vivo laminar imaging, thus further bridging the gap between
cellular and systems neuroscience